Recruitment, Retention, and Community Engagement Core

The UM Pepper Center Recruitment, Retention, and Community Engagement Core (RRCEC) provides the
critical infrastructure and resources essential for UM Pepper Center investigators conducting clinical and
translational research. Closely aligned with the UM Pepper Center’s goal of integrating bench, clinical, and
outcome research with clinical practice, the RRCEC collaborates with the LAC, REC, PESC, and the other
three Resource Cores to support UM Pepper Center-funded pilots and other externally funded projects (EPs)
related to the Center's central research theme. Formerly the Human Subjects and Assessment Core (HSAC),
the focus of the RRCEC has expanded to not only continue supporting clinical aging research but also to
enhance community engagement efforts, strengthen recruitment and retention of research participants more
broadly across the geographic region, and foster the next generation of aging researchers. Priorities include
supporting early career investigators new to aging research, translating basic research discoveries into human
studies, and advancing high-impact clinical trials that promise to maintain or improve physical and cognitive
function in older adults. The Specific Aims of the RRCEC are: 1. To expand and promote research on the
predisposing factors, metabolic factors, infections and inflammation mediators and functional and health
outcomes in the UM Pepper Center focus; 2. To provide training, consultation, and mentoring to UM Pepper
Center researchers on issues related to experimental design (pre- and post-award), recruitment/retention of
research participants from a range of sources including population-based data sets, and compliance with NIH
and institutional policies regarding human research; 3. To enhance community engagement to promote older
adults’ participation in aging research and facilitate the dissemination of Pepper Center research in a variety of
local and academic communities.